Osteocytes-bacteria interaction via NOD1 as a mechanism of bone loss in periodontitis

Project Summary/Abstract
Periodontal disease (PD) is a prevalent disorder affecting nearly half of US adults. Bacterially induced PD is a
leading cause of tooth loss. Around 20% of the patients do not respond to current treatment, and PD remains a
global health problem. In order to develop novel strategies to prevent tooth loss caused by PD, an improved
understanding of the molecular mechanism of alveolar bone loss is needed. Osteocytes are the most abundant
bone cells embedded in the bone matrix. Osteocytes orchestrate bone resorption by osteoclasts and bone
formation by osteoblasts, playing a vital role in maintaining bone homeostasis and the progression of skeletal
diseases. Recently, we and others have demonstrated that osteocytes are a crucial source of RANKL for bone
loss in PD. Additionally, we have shown that bacterial stimulation of osteocytes induces RANKL and significant
bone loss, indicating bacterial detection by osteocytes could be a mechanism of PD bone loss. Nucleotide-
binding oligomerization domain containing 1 (NOD1) is an intracellular pattern recognition receptor that
selectively recognizes specific types of peptidoglycan fragments primarily found in gram-negative bacteria.
Periodontal pathogenic bacteria, including Porphyromonas gingivalis (Pg), Fusobacterium nucleatum (Fn), and
Aggregatibacter actinomycetemcomitans (Aa), activate NOD1 signaling and induce inflammatory responses in
host cells. Additionally, NOD1-deficient mice are protected from inflammation and osteoclastic bone resorption
in the mouse ligature-induced periodontitis (LIP), revealing that NOD1 is a regulator of host responses in PD and
that LIP is a beneficial model to study the impact of NOD1 on PD bone loss. Recently, we discovered that
osteocytes increased Rankl expression in response to NOD1 stimulation, suggesting that the detection of
periodontal pathogens by osteocyte NOD1 could be a key mechanism of bone loss in PD. However, it remains
unknown whether periodontal pathogens can directly activate osteocyte NOD1 and whether osteocyte NOD1 is
a driver of bone loss in vivo. We hypothesize that osteocyte NOD1 senses peptidoglycan fragments that are
derived from periodontopathic bacteria to induce RANKL in PD, resulting in bone loss. To test our hypothesis,
we propose the following specific aims. Aim 1: Identify whether osteocytes use NOD1 to recognize periodontal
pathogens for their activation and RANKL induction. We will stimulate osteocytes with periodontopathic bacteria,
Pg, Fn, and Aa, with or without genetic or pharmacological inhibition of NOD1, and analyze RANKL expression.
Aim 2: Determine whether the lack of NOD1 in osteocytes protects alveolar bone from mouse LIP. We will delete
NOD1 in osteocytes (Dmp1-Cre Nod1fl/fl) and challenge the mice with LIP to determine the role of osteocyte
NOD1 in LIP bone loss. The outcome of this R03 will be the vital foundation for the future R01, where we will
investigate the mechanism of NOD1-induced Rankl transcription in osteocytes, the potential of systemic or local
administration of NOD1-specific inhibitors as a therapeutic approach for PD bone loss, and the characteristics
of peptidoglycan fragments from periodontal pathogens and mechanisms for their production.

Public health relevance
Project Narrative This project is relevant to public health in that it will elucidate the novel mechanism of bone loss in periodontal disease, which is a highly prevalent disease and a leading cause of tooth loss. Outcomes from the project will lead a new alternative treatment strategy to conventional treatment of periodontitis. The insights gained in this project can also be applied to other bone infectious conditions, such as peri-implantitis, periapical periodontitis, osteomyelitis and joint replacement infection.